Study in Outpatient Medicine using Nudges to improve Sleep: The SOMNUS Trial

ABSTRACT
Sedative-hypnotic "z-drugs" are dependence-forming substances associated with falls, fractures, high-risk
parasomnias (sleepwalking, sleep-driving), and cognitive impairment. However, these drugs are popular and
are usually prescribed long-term for insomnia, despite guideline recommendations to limit their use and to
favor cognitive-behavior therapy for insomnia. Behavioral economic nudges delivered in the electronic health
record are a promising way to encourage the use of cognitive-behavioral bibliotherapy and phone apps for
insomnia and to reduce high-risk Z-drug prescribing. Nudges are insights from behavioral science that fit into
existing clinical workflows, intended to preserve choice but influence decision-making toward desired behavior.
We propose the Study in Outpatient Medicine using NUdges to improve Sleep (SOMNUS) in response to
NHLBI's Notice of Special Interest (NOT-HL-21-010). The SOMNUS trial will simulate the long-term outcomes
of our nudging strategy using microsimulation from our Roybal Center for Behavioral Interventions in Aging's
Future Americans Model (Aim 1), align workflow and nudge performance in the electronic health record to
develop the best choice architecture (Aim 2), and conduct a randomized trial of minimally disruptive changes to
the electronic health record to encourage the use of evidence-based therapies for insomnia in everyday clinical
practice at 60 clinics in the U.S. (Aim 3).
The trial will employ the following two nudge concepts: 1) Social Accountability Nudges that ask a clinician
seeking to prescribe a Z-drug to either justify, in a brief free-text response, the reason for a
guideline-discordant action or to cancel the order, and to precommit to a brief deprescribing plan whenever
prescribing a Z-drug; 2) setting default days supply, pre-populated in the medication order, to a small number
of pills. In an 18-month trial involving 60 clinics (449 clinicians), clinic-clusters will be randomized to receive a)
social accountability nudges, b) defaults, c) both social accountability and defaults, or d) no intervention
(education control). The primary outcome measure is the change in Z-drug days supply ordered per patient.
Secondary outcomes include probability of starting a new patient on a Z-drug, probability of discontinuation
among long-term users, and a physician perceptions survey. To aid in deprescribing Z-drugs, we will also
provide bibliotherapy, access to insomnia, referrals for screening for related problems and visit assessments.
Sample size calculations indicate an 88.5% (95% CI: 83.3, 92.6) power to detect a 6.7% decrease in pills
ordered. This proposal will integrate behavioral economic approaches into implementation research to
encourage evidence-based decisions involving the treatment of insomnia. It will improve the safety and efficacy
of everyday clinical practice for people visiting their physician with sleep problems. It will also provide estimates
of the benefits of treatment to future Americans.

Public health relevance
NARRATIVE Long-term use of sedative hypnotics is associated with dependence, falls, fractures, high-risk parasomnias (sleepwalking, sleep-driving), and cognitive impairment. Despite this and guideline recommendations limiting their use, these drugs are the most popular pharmaceutical insomnia treatment. The objective of the Study in Outpatient Medicine using NUdges to improve Sleep (the SOMNUS Trial) is to develop and test behavioral nudges in a randomized trial to deprescribe these drugs and encourage the use of evidence-based therapies for insomnia in everyday clinical practice.